Development of peptide nucleic acid antibiotics

The world is rapidly heading towards a pre-1940’s scenario when it comes to fighting infectious disease.
Antimicrobial resistance is a growing problem on a global scale, greatly hampering our abilities to quell worldwide
epidemics such as influenza, SARS, COVID-19, tuberculosis and malaria, as well as the simple staphylococcus
infection. Unless innovative strategies are developed to produce robust and effective new classes of antibiotics,
health care costs will continue to climb and we will completely lose our ability to combat even the most common
infection. Influenza and coronavirus (SARS and COVID-19) create an even more urgent need for targeting
resistant bacteria related to lung infections, such as carbapenem-resistant Enterobacteriaceae (CRE), a common
example of CRE being Klebsiella Pneumoniae (KP). Recent article by J. Gerberding, former CDC director states
“The patients at greatest risk from superbugs like CRE and other bacterial pathogens that cause lung diseases,
are the ones who are already more vulnerable to illness from viral lung infections like influenza, severe acute
respiratory syndrome (SARS), and COVID-19. The 2009 H1N1 influenza pandemic, for example, claimed nearly
300,000 lives around the world. Many of those deaths — between 29% and 55% — were actually caused
by secondary bacterial pneumonia, according to the CDC.” A recent study (Zhou, Lancet 2020, 395, 1054-1062)
from Wuhan reports that almost 50% of COVID-19 related deaths showed evidence of secondary bacterial
infections (pneumonia, sepsis, bloodstream infections).
Cases of multidrug-resistant (MDR, resistance to 2-3 classes), extensive drug resistance (XDR, resistance to
most classes except colistin or tigecycline) and even pan drug resistance (PDR, resistance to all classes)
nosocomial bacterial infections have skyrocketed in recent years, and the emergence of pan drug-resistant
isolates are making these infections increasingly difficult to treat. Hospital-acquired infections like these account
for up to 4% of all hospital stays in the United States and are incredibly diverse in causative pathogen, antibiotic
resistance profile, and severity. A significant cause of nosocomial infection is the Enterobacteriaceae family,
which includes Gram-negative bacilli that can be commensal or pathogenic. Enterobacteriaceae have a
widespread clinical and economic impact due to the diversity of infections they cause; this family causes many
infections such as pneumonia, bloodstream infections (BSIs), urinary tract infections (UTIs), and intra-abdominal
infections (IAIs). The World Health Organization (WHO) lists carbapenem-resistant Enterobacteriaceae (CRE)
as having a critical need for novel antibiotics on their Priority Pathogens list. Because the mortality of these multi
drug-resistant infections is between 30 and 50% and there is such difficulty in finding viable treatments, the need
for novel therapeutics for these pathogens must be addressed.
One of the challenges of research in infectious diseases is to find ways to use the increasing knowledge of the
mechanisms underlying disease biology, transformation and progression to develop novel therapeutic strategies
targeting MDR, XDR, and PDR bacterial infections. Targeting heavily conserved RNA sequences and structures,
present in the 4 billion years old bacterial ribosome, and involved in proliferation and survival of bacteria, is a
promising approach. RNA, the essential nucleic acid component of the ribosome, is a validated target for drug
design, both as therapeutic and as a target. We will target specific rRNA single strands, which are conserved
across prokaryotes, essential for translation initiation but absent in eukaryotes, ensuring that a drug targeting
this sequence can function as a broad spectrum therapeutic. In the proposed work, we will construct sequence-
specific chemically modified rRNA targeting oligomers that can be effectively delivered inside the cell. Short RNA
will be exploited as target for synthetic molecules that inactivate the functioning of the ribosome, stopping
bacterial protein synthesis and causing bacterial death. NUBAD’s unique experimental approaches and
technologies will allow us to target rRNA combinations not previously explored for susceptibility against bacteria.
The work proposed is a multidisciplinary effort encompassing solid-phase organic synthesis, oligonucleotide
stability and delivery, RNA targeted screening, antimicrobial activity, ADME TOX, and in vivo efficacy studies
describes the development of sequence-specific cell permeable binders of rRNA. The success of the proposed
work would be a significant addition to currently available ribosome-specific approaches in drug development.
We propose using a small rRNA target sequence, heavily conserved in prokaryotes, to design conjugates that
can be employed to inhibit microbial growth, opening possibilities for developing sequence-specific RNA targeted
therapeutics. This work addresses an important world health issue, antimicrobial resistance, and presents
creative steps towards a novel solution to this problem.

Public health relevance
The work proposed here, a multidisciplinary effort encompassing organic synthesis, oligonucleotide delivery, RNA targeted screening and antibacterial studies, describes the development of sequence-specific cell permeable binders of rRNA as antibacterial therapeutics. The success of the proposed work would be a significant addition to currently available ribosome-specific approaches in broad spectrum antibacterial antibiotic development, in particular for targeting gram negative pathogens such as carbapenem-resistant Enterobacteriaceae (CRE). We propose using a small rRNA target sequences to design conjugates that can be employed to inhibit bacterial growth, opening possibilities for developing sequence-specific RNA targeted therapeutics.